Antagonize Host Survival and Immune Escape Mechanisms for Elimination of HIV Viral Reservoirs

PROJECT SUMMARY
The global rate of HIV infection and number of AIDS related deaths have dramatically declined thanks to the
expanding access to combination antiretroviral therapy (cART). However, current cART is only able to suppress
acute replication of HIV but fails to eliminate it. HIV epidemic remains unsolved and new HIV infections still occur
at a remarkable rate worldwide. Furthermore, HIV infection, even under control of cART, still persistently
associates with the chronic immune activation that attributes to the significant increase of risk for inflammation-
related diseases and the accelerated aging process. Identification of novel host-HIV interactions critical to HIV
infection will not only improve our understanding of HIV infection courses, but also accelerate the finding of new
strategies to develop antiretroviral agents perturbing host regulatory factors, which can efficiently eliminate HIV,
leading to a HIV/AIDS cure. Following HIV infection, Nef is expressed as one of the earliest and most abundant
viral proteins and important to establishment of HIV persistent infection. Our recent studies have identified that
HIV Nef plays a role in enhancing SUMOylation of polo-like kinase 1 (PLK1) and leading to its nuclear
accumulation. We provided the evidence that depletion or inhibition of PLK1 promotes cell death of HIV-infected
CD4+ T cells and facilitates elimination of HIV reservoirs. In this proposal, we aim to investigate the Nef-PLK1
axis based on our hypothesis that PLK1 is Nef’s host effector that executes its key function to promote cell
survival and immune escape, thus supporting HIV persistent infection. We will investigate the molecular insights
for HIV Nef to activate PLK1 protein SUMOylation and its nuclear accumulation. We will also dissect the signaling
transduction of PLK1 to promote survival and immune escape of HIV reservoir cells. Beyond the fundamental
studies, we will test the potential of small-molecule inhibitors targeting PLK1 as the reagents for elimination HIV
reservoirs. It is well acknowledged that simian immunodeficiency virus (SIV) infection of macaques closely
resembles HIV infection of humans, which serves as the best available animal model for studying progression
and pathogenesis of AIDS. We will determine whether the function of Nef-PLK1 axis is conserved in SIV infection.
We will also evaluate whether PLK1 inhibition is potent to eliminate SIV reservoirs. In Aim 1, we will investigate
HIV/SIV Nef’s role in controlling PLK1 protein modifications and functions. In Aim 2, we will determine PLK1’s
role in promoting survival and immune escape of HIV/SIV reservoirs. In Aim 3, we will evaluate therapeutic
potential of PLK1 inhibitors for eliminating HIV/SIV viral reservoirs ex vivo.

Public health relevance
PROJECTIVE NARRATIVE Despite of potent antiretroviral therapies, HIV infection still persists attributing to the chronic inflammation and the accelerated aging-related diseases, thus requiring its elimination for a cure. We identified that HIV Nef protein induces polo-like kinase 1 (PLK1) through increase of its protein SUMOylation and nuclear accumulation, and propose to study PLK1 as a Nef’s novel host effector to promote survival and immune escape of HIV/SIV viral reservoirs. Chemical compounds targeting PLK1 will be investigated in terms of their therapeutic potential to reduce or eliminate persistent HIV/SIV viral reservoirs ex vivo.